Androgen receptor signaling and sex differences in anti-tumor dendritic cell function

PROJECT SUMMARY
Sex differences in cancer have been clearly documented. In general, males have higher incidence rates and
poorer outcomes compared to females. This difference is particularly pronounced in melanoma where females
have a 38% survival advantage compared to males after adjusting for stage at diagnosis. Sex-based differences
in immune function likely contribute to the sexual dimorphism observed in cancer. The female immune response
has been characterized as more robust, mounting better responses to infection and vaccination than males.
Further, androgens have been shown to be widely immunosuppressive. In multiple preclinical tumor models,
including melanoma, androgen signaling through the androgen receptor (AR) has recently been shown to directly
suppress anti-tumor T cell function. Notably, T cell function is only one aspect of the immune response.
Conventional dendritic cells (cDCs) prime naïve T cells and serve to initiate and expand an antigen-specific, anti-
tumor immune response. In melanoma, cDCs are required to generate a CD8+ T cell response against the tumor.
However, how AR impacts anti-tumor function of cDCs is entirely unknown. Given the striking sexual dimorphism
in immune system function and cancer, and the importance of cDCs in anti-tumor immune responses, there is a
clear and urgent need to investigate the impact of AR signaling in cDCs. In preliminary studies in mice, we found
that antigen-bearing cDCs from both male and female melanoma draining lymph nodes express AR. Importantly,
we confirmed that human bone marrow derived cDCs (BMDCs) also express AR. To address the direct impact
of AR-signaling on cDC function and anti-tumor immunity, we created a novel mouse model that specifically
lacks AR in cDCs. Strikingly, these mice showed delayed melanoma tumor growth and significantly improved
CD8+ T cell activation compared to AR-proficient control animals. Given our preliminary data, our central
hypothesis is that cDC-intrinsic AR activity limits cDC function and impairs anti-tumor immunity. Here we propose
to: i) identify the functional impact of cell-intrinsic AR signaling on cDC anti-tumor function using a novel mouse
model where AR is deleted specifically in cDCs; ii) address the role AR in directly modulating expression of MHCI
and use single-cell transcriptomics to elucidate the cDC-specific, AR-dependent, gene expression pathways
driving immunosuppression; and iii) determine the efficacy of an AR-deficient, cDC-based, anti-cancer vaccine.
We expect our work to contribute the mechanistic biology needed to understand how AR signaling in cDCs
suppresses anti-tumor cDC function in males and females. This work will also provide key, preclinical, proof-of-
concept data for targeting AR clinically in cDCs to improve cell-based vaccine efficacy. Broadly, these findings
will improve our understanding of androgen-mediated immune modulation and support the integration of biologic
sex as a variable in immunotherapeutic decisions.

Public health relevance
PROJECT NARRATIVE Sex differences in immune function are well documented, however, how these differences impact anti-tumor immunity and immunotherapy response in melanoma remain unclear. This proposal will address the role of androgen receptor signaling in dendritic cell function and the downstream consequences for anti-tumor T cell activation in males and females. Using a novel mouse model and human samples, the goal of this work is to provide mechanistic, preclinical, data to support leveraging androgen receptor activity in dendritic cells to improve cell-based vaccine efficacy.